Type I Interferon Regulation of Tumor Cell and Immune Cell Interaction in Human Colon Cancer

Project Summary
IFN was an FDA-approved agent for human cancer therapy and is currently used as exogenous
recombinant protein or protein prodrugs. The use of IFN in human cancer therapy has been limited by the
ineffective dosing and high toxicity. This proposal develops a lipid nanoparticle encapsulated IFN-encoding
DNA nanoplasmid (IFNA13CO01) to force tumor cells to express and produce endogenous IFN13 locally in
the tumor microenvironment. IFNA13CO01 therapy is therefore expected to produce high level of endogenous
IFN13 locally in the tumor site and thus overcomes the ineffective dosing and systemic toxicity issues
associated with the current IFN agents. In the preliminary studies, we determined that type I interferon (IFN-I:
IFN and IFN) expression level is significantly lower in human colorectal carcinoma than in normal colon
tissue. We further determined that IFN-I functions in both tumor cells and T cells are essential for host cancer
immune surveillance. Mechanistically, we determined that IFN-I activates STAT3 that binds to the Gzmb
promoter to activate Gzmb transcription in CTLs. The IFN-I/STAT3/Gzmb axis thus is essential for CTL anti-
tumor function. In addition, we determined that tumor cell expressed PD-L1 (tPD-L1) engages myeloid cell
expressed PD-1 (mPD-1) to antagonize IFN-I and STAT1 signaling to repress Cxcl9 and Cxcl10 to impair CTL
recruitment to lung metastases. Human patient response to PD-1 blockade immunotherapy correlates with
IFN-I response in myeloid cells. We therefore discovered that the tPD-L1/mPD-1/IFN-I/STAT1/Cxcl9-Cxcl10
axis controls CTL tumor infiltration in lung metastasis. Our central hypothesis is that forcing tumor cells to
express and produce endogenous IFN13 in the local tumor microenvironment via IFNA13CO01 therapy is an
effective and yet safe approach to suppress human colorectal tumor growth and progression. We propose to
test our new central hypothesis by pursuing the following 3 specific aims: 1) Test the hypothesis that tPD-1
engages mPD-1 to inhibit IFI-I signaling to suppress CTL recruitment and function to promote metastatic tumor
growth in human colon cancer patients.; 2) Determine the efficacy of IFNA13CO01 in suppression of
metastatic human colon cancer PDX growth in humanized NSG mice; and 3) Determine IFNA13CO01
biodistribution, toxicology and pharmacokinetics in vivo.

Public health relevance
Project Narrative Approximately one million veterans aged 50 and older will develop colorectal cancer over the remainder of their lives and nearly 433,000 will die from it. On a national basis, the relative five year survival with colorectal cancer was estimated at only approximately 40% among veterans, substantially lower than the 60% survival rate among the general population. Myeloid cell accumulation is a hallmark of human colorectal cancer and PD-L1 is a major immune suppressive ligand of MDSCs. In the preliminary studies, we determined that PD-L1 engages PD-1 of myeloid cells to inhibit type I interferon signaling to suppress CTL tumor infiltration. Therefore, it is critical to study type I interferon signaling in myeloid cells in human colorectal cancer patients. The proposed studies have the potential to determine the role of tPD-L1 and mPD-1 in colon cancer immune evasion and will provide the basis for molecular mechanism-based development of IFNA13CO01 for human colon cancer immunotherapy.